Decoding Hippocampal-Parietal contributions to spatial navigation in a mouse modeling Tau and AB aggregation features of Alzheimer's Disease

Project Summary/Abstract
Alzheimer’s disease (AD) is devastating for both individuals and society. Because pathology and
neural damage occur so early relative to detectable symptoms, it is important to study early
disease progression, with a focus on detection and treatment. One of the earliest symptoms to
appear in this disease is impairments in spatial navigation, which could be the result of
impairments in navigational computations, memory encoding or retrieval, or some combination of
navigational and memory impairments. Both cortex and hippocampus are important for memory
encoding and navigational computations, with interactions between these two regions supporting
these processes. In navigation, hippocampus is involved in creating a cognitive representation of
the environment. Parietal cortex is involved in the translation of this cognitive representation
based on body-centered location into the appropriate navigation decision. Furthermore,
interactions between these regions have been shown to be impaired during sleep in rodents
modeling Tau and amyloid beta (Aβ) aggregation aspects of AD. Thus, we will test the hypothesis
that impaired hippocampal-cortical interactions during navigation underlie deficits in spatial
navigation in a mouse modeling Tau and Aβ aggregation (TAβA; AIM 1). Additionally, we will test
the hypothesis that these interactions can be rescued via 40Hz stimulation of either parietal cortex
or hippocampus (AIM 2). This project will expand our knowledge of systems level dysfunction as
a consequence of TAβA, and how this impacts cognitive symptoms. Furthermore, this project will
provide insight into how new, preliminary treatments for AD designed to ameliorate TAβA effects
systems, spatial navigation, and neural function.

Public health relevance
Project Narrative One of the earliest symptoms of Alzheimer’s disease to appear is deficits in spatial navigation, or getting lost in space, which involves complex interactions across multiple brain regions. This research project will look at how these interactions may be affected by Alzheimer’s disease, causing losses in spatial navigation, and will utilize a noninvasive approach for clearing amyloid beta and tau and rescuing functional interactions. This research will also expand our understanding of Alzheimer’s effects on spatial navigation, and will aid in understanding what mechanisms underlie these deficits, to improve early identification and treatment strategies.